Molecular Mechanism of Huntingtin Misfolding and its Inhibition by Designed and Cellular Proteins

Abstract
Huntington disease (HD) is one of many neurodegenerative diseases wherein accumulation of misfolded,
aggregated protein is a pathogenic mechanism. HD is caused by polyglutamine expansions in the huntingtin
protein which make it and its naturally occurring exon 1 fragment (Httex1), more aggregation prone. We have
shown that Httex1 aggregation is a stepwise process, wherein the monomer gives rise to different aggregation
intermediates prior to formation of fibrils. Although there is good consensus that Httex1 aggregation plays a key
role in disease pathogenesis, less is known about the 3D structures of Httex1 aggregation intermediates and
how each conformer contributes to toxicity. A major obstacle in the field has been the difficulty in obtaining
homogeneous population of these conformers for their biochemical characterization. We have recently identified,
stably prepared, and characterized different different intermediates during Httex1 aggregation. We propose to
extend this work by determining the structure of key conformers (α-helical oligomer and unbundled fibril) and by
investigating different mechanism by which misfolding and toxicity can be inhibited. Using our array of different
conformers, we also expect to obtain detailed insight into the how chaperones recognize Httex1 conformers. By
combining EPR, solid-state and solution NMR, cryo-EM, and cell toxicity assays, our team is in a unique position
to successfully accomplish these goals. In Aim 1, we will combine EPR, NMR, cryo-EM and computational
refinement to determine the structure of unbundled fibrils from Httex1 proteins with different Q-lengths. By
learning about the structures of these toxic conformers, we enable future efforts aimed at finding biomarkers and
aggregation inhibitors. The structure of the earliest misfolding intermediate, the α-helical oligomer, will be
determined in Aim 2A. This will be done using EPR, solution NMR, and cryo-EM. We also obtained a fibril binder
from small, multimerized N17Q7 peptides which potently inhibits Httex1 aggregation. Specific aim 2B tests the
hypothesis that this binder inhibits aggregation by interfering with primary and/or secondary seeding. Moreover,
we will optimize the inhibitor and test its ability to protect from toxicity in a cellular setting. Specific aim 3
determines how chaperones recognize Httex1 misfolding. Using a combination of biochemical methods, EPR,
NMR and cryo-EM, we will identify the molecular mechanism by which chaperones (DNAJB1 and DNAJB6) bind
to Httex1 by determining which Httex1 conformers the they bind to and which epitope they are recognizing.

Public health relevance
Project narrative The aggregation of the huntingtin protein plays an important role in Huntington’s disease, but the exact structures of the toxic species that are formed remain elusive. Using a highly interdisciplinary team, the structures of these species will be determined, thereby providing a foundation for the design of therapeutics. Moreover, means to prevent the formation of the toxic species will be developed.